ROLES AND MECHANISMS OF TERTIARY LYMPHOID STRUCTURES IN ANTI-TUMOR IMMUNITY

PROJECT SUMMARY
Tertiary lymphoid structures (TLS) are T and B lymphocytes in aggregation with antigen presenting cells,
fibroblasts, and high endothelial venules observed in some chronically inflamed tissues. TLS formation in tumors
of cancer patients is associated with improved adaptive immune function and increased overall survival. In
surgically resected human pancreatic ductal adenocarcinoma (PDAC), a significant proportion of patients form
spontaneous TLS in their primary tumors. Other groups have demonstrated similar findings, but no evidence
currently exists showing TLS directly influence T cell immunity. In this application we propose to investigate if
TLS enhance T cell immunity in the context of PDAC tumorigenesis and the mechanism of how this occurs. Our
preliminary data in TLS+ mouse and human PDAC tumors shows TCF1+ stem-like T cells (T-stem) are enriched
specifically within TLS relative to the surrounding tumor and stroma. We posit that TLS in PDAC tumors support
the development of stem-like T cell phenotypes (T-stem), dependent on interleukin-21 signaling. These unique
T cell subsets have previously been shown to sustain cellular immunity during chronic infection and cancer,
providing continual repletion of memory, effector, and terminally differentiated cells following antigenic recall or
immune checkpoint blockade treatment. We model this biology using a panel of mouse PDAC cell lines derived
from transgenic mouse tumors that conditionally express mutant KRas and p53, the most common driver
mutations in PDAC, and encode for a model MHCI-restricted antigen to track tumor antigen-specific responses.
These cancer cell lines, despite sharing a similar genetic and mutational background, induce tumors with unique
phenotypes and heterogenous tumor microenvironments. We will deploy a novel method to induce TLS in these
mouse tumors through lymphotoxin beta receptor (LTBR) agonism, whereby some of our mouse tumor lines are
permissive for TLS formation and others are resistant. We will test if the TLS-mediated generation of T-stem is
responsible for improved tumor control in CD8 conditional TCF1-knockout mice. We will determine if their
enrichment in TLS is due to IL-21 signals derived directly from TLS that promote their formation, independent of
lymphatic involvement, utilizing a combination of cell lineage tracing and genetically modified mouse models.
We will complement these studies by investigating tumor samples from PDAC patients for phenotypic pathways
unique to specific regions of these tumors. We will achieve this by performing spatial transcriptomics on human
PDAC tumor sections analyzed by an innovative algorithm that transforms spatial variable genes into functional
tissue modules to determine region-specific immune phenotypes localized to the TLS compared to non-TLS
regions and tumors without TLS. This approach identifies the mechanism of how TLS supports T cell function in
authentic mouse models of TLS+ PDAC and translates these findings to human cancer patients so novel
immunotherapy options designed to elicit and activate TLS can be offered to patients with a treatment resistant
malignancy.

Public health relevance
PROJECT NARRATIVE The presence of tertiary lymphoid structures (TLS) in solid tumors is prognostic for survival in cancer patients, including pancreatic ductal adenocarcinoma, associated with the expression of MHCI-neoantigens and markers of enhanced immune memory. However, there is no evidence that TLS directly augment tumor specific T cell immunity or the mechanisms of how this occurs. We hypothesize that TLS in pancreatic tumors promote the differentiation of stem-like T cells through IL-21 programming, thereby enhancing effector T cell responses leading to improved tumor control.